Novobiocin-mediated polymerase theta inhibition in homologous recombination repair-deficient cancers

PROJECT SUMMARY/ABSTRACT
Homologous recombination (HR) repair-deficient cancers are dependent on polymerase theta (POLq)-mediated
DNA end joining, so that POLq is a candidate target for these cancers. This reliance extends to the PARP
inhibitor-resistant state, where POLq limits excessive DNA end resection and RAD51 loading, preventing the
accumulation of toxic intermediates. POLq deficiency has also been linked to micronucleation, a process
associated with activation of innate immunity. Through high-throughput small molecule screens, we have
recently identified the antibiotic novobiocin (NVB) as a specific POLq inhibitor that selectively kills HR-deficient
cells in vitro and in vivo, including those with acquired PARP inhibitor resistance, suggesting that NVB may be
useful alone or in combination with PARP inhibition in treating cancers with HR alterations. NVB also induces
micronucleation and consequent cGAS/STING pathway activation in HR-deficient cells. In the first Specific Aim,
multiple cell line and patient-derived xenograft models of BRCA-mutant breast, ovarian and pancreatic cancer,
including those that are PARP inhibitor-sensitive and those with acquired PARP inhibitor resistance, will be
studied for response and pharmacodynamics of NVB combined with the PARP inhibitor talazoparib to compare
combinatorial antitumor and biological efficacy to that achieved by monotherapy. Pharmacodynamic effects will
be assessed using g-H2AX, pRPA and RAD51 foci as biomarkers of DNA damage, end resection and RAD51
loading, respectively, to pilot their utility for clinical trial. In the second Specific Aim, we will conduct Phase 1
clinical trials of NVB monotherapy and NVB combined with talazoparib in patients with advanced solid tumors
harboring HR alterations. The monotherapy study will utilize a BOIN design to determine the recommended
phase 2 dose of chronic monotherapy and the combination trial will utilize a waterfall design to define the MTD
contour over a two-dimensional dose matrix. Both studies will evaluate pharmacokinetic parameters and
incorporate paired biopsies for pharmacodynamic endpoints to establish proof-of-mechanism. The minimum
biological effective dose of NVB will be determined in the monotherapy trial, which will guide dosing in the
combination study. In the third Specific Aim, NVB used alone and combined with talazoparib will be studied for
induction of cGAS/STING activation in vitro, as well as in an immunocompetent genetically engineered mouse
model of BRCA-deficient breast cancer. The effects of NVB and NVB/talazoparib on the immune
microenvironment will be comprehensively characterized and antitumor activity will be assessed in the absence
and presence of immune checkpoint blockade. Taken together, the preclinical and clinical studies in this project
are designed to advance NVB-mediated POLq inhibition in the armamentarium for HR-deficient cancers.

Public health relevance
PROJECT NARRATIVE Although PARP inhibition has transformed the treatment of homologous recombination (HR) repair-deficient cancers, strategies to prevent, or reverse acquired resistance represent an unmet medical need. To exploit the synthetic lethality of polymerase theta (POLq) and HR deficiency, the recently identified POLq inhibitor novobiocin (NVB) will be studied as monotherapy and in combination with talazoparib in BRCA-deficient, PARP inhibitor-sensitive and resistant preclinical models, including those that are immunocompetent. Results will be translated to early phase clinical trials, with the ultimate goal of improving outcomes for patients with advanced cancers harboring HR alterations.